Antioxidant Imaging Marker of Investigating Gains in Neurocognition in an Intervention Trial of Exercise (AIM-IGNITE)

PROJECT SUMMARY / ABSTRACT
The absence of effective methods for treating age-relate cognitive decline presents a significant public
health problem, considering its ubiquity with unprecedented increases in the aging population. Recently,
lifestyle choices, particularly exercise, have been noted as potential effective strategies for maintaining and
enhancing brain health and cognitive function in older adults. However, the public and scientific community is
yet to reach agreements on the conclusive benefits of exercise on the brain. Currently a Phase III clinical
trial: IGNITE (Investigating Gains in Neurocognition in an Intervention Trial of Exercise) is ongoing to address
the ambiguity in influences of exercise on brain health and cognitive function in older adults. We propose an
ancillary study to determine the impact of exercise on antioxidant status in the brain of participants drawn
from IGNITE, in which clinical, imaging, genetic, molecular and physiological measures will be acquired. We
will determine the association of antioxidant status with cognitive function and brain health as well as the
impact of genetic and molecular risk factors of Alzheimer's disease (AD) on these relationships.
Our long-term goal is 1) to identify the underlying mechanisms of improved brain health and cognitive
performance associated with behavioral interventions and/or new targeted therapies in older adults, and 2) to
offer novel possibilities for directly monitoring the impact of these emergent treatment options through new
quantitative, non-invasive neuroimaging indices of brain health in aging, AD and AD-related diseases. Our
overall hypothesis is that exercise enhances cerebral antioxidant defenses to fight against oxidative stress in
the aging brain by increasing the levels of glutathione (GSH), which leads to improved brain health and
cognitive function. GSH is a key component of the cerebral antioxidant system, which is consumed to protect
cells against oxidative damage resulting in lower GSH levels in brain tissue.
Our preliminary data suggest that brain GSH is related with the cognitive performance of older adults in
multiple domains, lowered in aging and AD, and increases after exercise interventions. The Specific Aims
are: (1) to determine the influence of exercise intervention on the brain antioxidant status in the aging brain,
(2) to determine the mediating relationship between the brain antioxidant status and exercise-associated
improvements in cognitive function and brain health, and (3) to examine modulating effects of
genetic/molecular markers of Alzheimer's disease on changes in brain antioxidant status after exercise
intervention. The expected outcome of this project is 1) the identification of a major mechanism, oxidative
stress, underlying the beneficial effects of exercise on cognitive function and brain health seen in older adults,
2) the identification of a mechanism-based neuroimaging marker reflecting neuromodulating effects of
exercise intervention and the dose-response effects, and 3) the identification of exercise intervention as an
important strategy to enhance neuroprotection via increased cerebral antioxidant defenses.

Public health relevance
PROJECT NARRATIVE Since the absence of effective methods for treating age-related cognitive decline presents a significant public health problem, this ancillary study of a Phase III clinical trial: IGNITE (Investigating Gains in Neurocognition in an Intervention Trial of Exercise) is designed to determine whether oxidative stress is an important mechanism involved in the beneficial effects of aerobic exercise on cognitive function and brain health in late adulthood for public guidance and health care recommendations based on the outcomes of IGNITE. Thus, the public health will be greatly served by the opportunity to improve brain function and prevent or slow down the onset of Alzheimer's disease and related diseases before the extensive age-related cognitive decline has taken place. Also, the resulting improvement in the quality of life for older adults is directly relevant to public health and to the mission of NIH.